TRANSIENT INSOMNIA--COMPARISON OF ZOLPIDEM AND TEMAZEPAM

This protocol describes a study designed to compare a new sleeping pill, zolpidem with a currently available preparation called tempazepam with regard to "morning after performance". This will be a multicenter study involving 15 centers and approximately 630 normal subjects, 42 of whom will be enrolled a the BWH. Subjects will be randomized to three treatment groups such that 3/7 will be in each drug group and 1/7 in placebo group.